Brain derived extracellular vesicles-mediated neurotoxicity of deltamethrin

ABSTRACT
Epidemiological studies identify early life exposure to pyrethroids as a threatening risk factor for attention-deficit
hyperactivity disorder (ADHD). Because the reported risk of exposure is within no-observed-adverse-effect level
(NOAEL) guidelines, environmental exposure to pyrethroids could be an underestimated leading cause of ADHD
and other neurodevelopmental disorders in the general population. Animal models of early-life exposure to the
pyrethroid pesticide deltamethrin (DM), a potent highly lipophilic molecule that accumulates in the brain,
recapitulate ADHD-like behavior through disruption of dopamine signaling in the nucleus accumbens, one of the
brain regions implicated in the human disease. Yet, the mechanism of toxicity of DM in other developing brain
regions has not yet been determined. Preliminary work from our group indicates that DM exposure disrupts brain
derived extracellular vesicles (BDEVs), molecules involved in communication between cells and regulating the
pathophysiology of several diseases. Further, early-life exposure to DM disrupts long-term potentiation in the
hippocampus, a phenomenon underlying learning and memory formation which is disrupted in childhood ADHD.
Building on this premise, we propose to characterize the altered biogenesis of BDEVs and its role in synaptic
injury induced by early-life exposure to DM (Aim 1) and to determine whether BDEVs derived from DM early-life
exposure are sufficient to induce DM synaptic and behavioral phenotypes associated with hippocampal function
in naïve animals (Aim 2). Outcomes of this study will provide new insights into the molecular-based
understanding of risk factors for neurodevelopmental disorders providing guidance for therapeutic development
against exposure.

Public health relevance
PROJECT NARRATIVE Evidence indicates that environmental exposure to pyrethroids, such as deltamethrin, at no-observed-adverse- effect level (NOAEL), increases the risk of neurodevelopmental disorders in the general population. Through an interdisciplinary approach that includes isolation and characterization brain-derived extracellular vesicles and their role in synaptic injury and dysregulation of hippocampal function caused by early-life exposure to deltamethrin using in vivo and in vitro models, we will provide a mechanistic model of neurotoxicity of pyrethroids in the developing brain. These studies will provide novel insights to evaluate the risk of neurodevelopmental disorders in the context of environmental toxin exposure.